Dopamine Neuronal Microcircuits Controlling Methamphetamine Seeking Behavior

Project Summary/Abstract
This proposal is being submitted to support the transition of Dr. Dominguez-Lopez from mentored trainee to
an independent investigator in the neurobiology of drug addiction, specifically studying the dopamine
microcircuits controlling drug-seeking behavior. Dr. Dominguez-Lopez works under the mentorship of Dr.
Michael Beckstead at the Oklahoma Medical Research Foundation (OMRF) investigating the role of
dopamine neurotransmission in the ventral tegmental area (VTA) in methamphetamine (METH) self-
administration behavior. Dr. Beckstead is a recognized expert in dopamine synaptic transmission in the fields
of addiction. Dr. Beckstead’s laboratory combines mouse models of drug self-administration with patch-clamp
electrophysiology and immunocytochemistry, providing a dynamic environment for Dr. Dominguez-Lopez to
become an experienced scientist. The submitted proposal incorporates scientific training in methodologies to
study mitochondrial metabolism, transcriptional analysis, bioinformatics and genetic labeling of active
neuronal populations. The applicant will be receiving training in educational methods, scientific writing, grant
preparation and other skills necessary to become an independent brain research scientist from an
underrepresented group. The proposed program includes mentoring interactions with Dr. Holly Van Remmen,
Dr. Willard Freeman, Dr. Linda Thompson, members of OMRF, and Dr. Rajeshwar Awatramani from
Northwestern University in Chicago. The short-term objective of this application is to enhance Dr. Dominguez-
Lopez’s knowledge of mitochondrial metabolism and single cell transcriptomics applied to dopaminergic
circuits. In the long-term, this will enable Dr. Dominguez-Lopez to secure protected time for training and
research activities, establish new collaborations, and pursue his novel independent research resulting in
competitive grant proposals. Preliminary data obtained by Dr. Dominguez-Lopez indicates that prolonged
METH self-administration in mice produces a decrease of dopamine neurons in the VTA, decreases dopamine
cell excitability, increases mitochondrial oxygen consumption rate and decreases levels of glutathione. These
observations are concurrent with increased drug-seeking behavior. This research proposal expands on those
findings to identify metabolic and molecular characteristics in dopamine circuits that provide resistance or
vulnerability to METH exposure. The central hypothesis is that a subpopulation of VTA dopamine neurons is
responsible for METH-seeking behavior, forming a microcircuit that is resistant to mitochondrial oxidative
stress induced by chronic METH exposure. The proposed aims are 1) Identification of VTA dopamine
microcircuits encoding METH-seeking behavior, and 2) Metabolic characteristics of VTA dopamine neurons
encoding METH-seeking behavior. Identification of the specific brain circuits responsible for METH addictive
properties is a first step to develop therapeutic strategies to help addicts recover from METH addiction.

Public health relevance
Project Narrative Understanding how dopamine neuronal circuits are affected by methamphetamine-induced mitochondrial oxidative damage will help to identify the cellular mechanism that leads to methamphetamine addiction. Here, we will use a cell to system integrative approach with transcriptomics, bioinformatics and viral neuronal tracing technologies to identify anatomical, metabolic, and molecular characteristics of dopamine microcircuits vulnerable or resistant to chronic methamphetamine self-administration. In the long-term, our research will contribute knowledge to develop novel therapeutics to offer a healthier life quality for those fighting addiction.